Novel Function of Ubiquitin-Like Protein 5 As a Fat Suppressor

Project Summary
Excessive lipid accumulation is central to the pathogenesis of prevalent metabolic diseases including fatty
liver. Substantial evidence supports a critical role for endoplasmic reticulum (ER) stress and the unfolded protein
response (UPR) in driving lipid accumulation and fatty liver development. However, the precise link from the ER
stress-UPR to ectopic fat storage remains elusive. In our preliminary studies, we identified ubiquitin-like protein
5 (UBL5) as a novel ER stress responder, undergoing rapid depletion in response to ER stress in mammalian
cell lines and in livers of mice. The ER stress-induced UBL5 depletion was mediated by the ubiquitin-independent
proteasome system (UIPS). The PKR-like ER kinase (PERK) arm of the UPR pathway was responsible and
sufficient for inducing UBL5 breakdown. RNA-Seq analysis revealed distinctly up- and down-regulated pathways
in UBL5-depleted cells. Most strikingly, UBL5 knockdown upregulated lipogenic programs and simultaneously
downregulated the fatty acid oxidation pathway. Functional analyses confirmed that UBL5 silencing promoted
de novo lipid synthesis and attenuated fatty acid oxidation, placing UBL5 at a unique nexus to control fat storage
by transcriptionally affecting the principal lipid anabolic and catabolic processes in opposite directions.
Consistent with this, UBL5-silenced cells and liver tissues showed excessive lipid droplets and dramatic increase
in cellular triacylglycerol content. These results reveal a novel function of UBL5 in suppression of lipid
accumulation and a regulatory/signaling mechanism to control UBL5 protein stability and activity by the UPR-
PERK arm.
Based on these observations, UBL5 offers a candidate link from ER stress to abnormal lipid accumulatio,
the hallmark of NAFLD. In further support of the pathophysiological relevance of UBL5, our additional preliminary
data showed that UBL5 protein was significantly reduced in fatty livers of mice fed high-fat diet (HFD) and in liver
biopsies of NAFLD patients. We have also developed ubl5 conditional knockout and liver-specific transgenic
models to explore the biological functions of UBL5 in vivo. We hypothesize that UBL5 is a fat suppressor
whose function is disrupted by recurring or chronic ER stress-UPR-PERK activation to promote lipid
storage and fatty liver development. The lipid burden itself could aggravate the cellular ER stress, further
depleting UBL5 protein and its fat-suppressive function in a vicious cycle toward the full phenotype of
inflammatory non-alcoholic steatohepatitis (NASH). We will examine the hypothesis by establishing a general
role and underlying mechanisms for UBL5 in suppression of lipid accumulation (Aim 1), identifying the key
components of the UIPS machinery involved in UBL5 degradation and the communication network from PERK
activation to UBL5 destabilization (Aim 2); and determining the biological relevance of the endogenous UBL5 to
the development and progression of NAFLD (Aim 3). These in vitro and in vivo studies will identify UBL5
dysfunction as a new mediator of NAFLD and a potential target for management of the disease.

Public health relevance
Project Narrative Non-alcoholic fatty liver disease (NAFLD) has become a major public health problem affecting more than 30% of the USA population. The burden of NAFLD among veterans is substantial. Our preliminary studies have identified a novel function of ubiquitin-like protein 5 (UBL5) in suppression of lipid accumulation and a regulatory/signaling mechanism to control UBL5 protein stability and activity by ER stress. In this project, we will explore the roles of UBL5 in lipid metabolism and its dysfunction in connecting chronic ER stress to NAFLD.